Mechanism of immune dysregulation secondary to methamphetamine abuse.

DESCRIPTION (provided by applicant): Methamphetamine (METH) abuse impairs host defense mechanisms and is thought to enhance host susceptibility to infections. High incidence of HIV-1 infection in METH abusers and potential effects of METH on the immune system underscore the clinical significance of METH-HIV-1 co-morbidity. Although METH abuse is implicated in dysregulation of immunity, the causal interrelationship between METH exposure and the inability to elicit protective adaptive immune response remains elusive. Acquired immunity, in particular CD8+T cell response, plays a pivotal role in control of HIV-1 infection. Lack of understanding of impact of METH abuse on acquired immune response in controlling HIV-1 infection warrants future considerations. Our preliminary data showed that METH exposure increased cytosolic calcium levels in primary human T cells leading to generation of ROS that correlated with mitochondrial injury and T cell dysfunction. We found that METH exposure altered gene expression regulating cell signaling, proliferation and differentiation, cell-mediated immune responses and transcriptional co-activation potentially contributing to METH-mediated T cell dysfunction. For the first time, we showed that trace amine associated receptor (TAAR1, a novel receptor activated by amines) is stimulated by METH on T cells implying that some of METH effects may be attributable to activity of this receptor. Using a combination of in vitro (molecular, biochemical and functional assays) and in vivo animal models of chronic viral infection (SCID mouse model for HIV-1 encephalitis and LCMV mouse model) chronically exposed to METH, we will address the following questions: (1) What are the pathophysiological effects of METH on T cell mitochondrial dynamics? (2) What are the underlying mechanisms and molecular consequences of METH-mediated mitochondrial dysfunction on T cells and what roles do they play in cell immune cell impairment? (3) What effects does METH-mediated immune dysfunction have on the host adaptive immune responses to chronic viral infections (HIV-1/LCMV infection)? We will identify mitochondrial substrates of METH and delineate pathways involved in these effects by using proteomic and molecular biological approaches. The proposed work is highly significant, as it will contribute to understanding of the underlying mechanisms of the combined effects of HIV-1 and METH abuse on adaptive immunity. Therapeutic approaches towards boosting T cell immunity based on these investigations will reduce persistent infection.

Public health relevance
PUBLIC HEALTH RELEVANCE: Methamphetamine, a highly addictive stimulant abused by millions of Americans and is known to alter immune function and increase susceptibility to infection. Epidemiological studies indicate growing evidence of the association between METH abuse and an increased incidence of HIV-1 infections. However, the apparent causal interrelationship between METH abuse and susceptibility to HIV-1 infection or its progression are largely unknown. Current proposal aims to understand putative mechanisms of immune dysfunctions in the setting of METH abuse and HIV-1 infection. Project Narrative: Methamphetamine, a highly addictive stimulant abused by millions of Americans and is known to alter immune function and increase susceptibility to infection. Epidemiological studies indicate growing evidence of the association between METH abuse and an increased incidence of HIV-1 infections. However, the apparent causal interrelationship between METH abuse and susceptibility to HIV-1 infection or its progression are largely unknown. Current proposal aims to understand putative mechanisms of immune dysfunctions in the setting of METH abuse and HIV-1 infection. __SpecificAimsTextDelimiter__ SPECIFIC AIMS: Illicit drug abuse such as methamphetamine (METH) affects various components of the immune system [1-9]. Associated to risky sexual behavior and rapid progression of HIV-1 infection, METH abuse is shifting the public health landscape at multiple levels [10]. Recent research suggests that mitochondrial oxidative damage and dysfunction contributes to a number of pathologic conditions and is associated with METH abuse [11, 12]. Conversely, the oxidative and immunotoxic effects of METH on T cells as a potential mechanism of METH-mediated immune suppression remain elusive. The objective of this application is: (1) to understand how METH affects mitochondrial T cell function; (2) to determine the signaling pathways mediating T cell dysfunction by METH; and (3) to provide "proof-of- concept" in vivo that METH enhances susceptibility to chronic infections (such as HIV-1) and their rapid progression. Previously, we found that METH exposure increased cytosolic calcium levels in primary human T cells leading to subsequent generation of ROS that correlated with mitochondrial injury and led to T cell dysfunction (Potula et al. in revision). Recently discovered novel transmembrane G protein coupled receptor, trace amine-associated receptor 1 (TAAR1) may represent putative target for a variety of monoaminergic compounds, including amphetamines [13, 14].Our preliminary results for the first time illustrate induction of TAAR1 expression in T cells in response to METH suggesting its immunomodulatory effects, in part attributable to the activity of the receptor. Based on these facts and following the lead of our preliminary data, we hypothesize that METH via induction of oxidative stress and mitochondrial injury alters specific cellular function leading to modulation of T cell function and homeostasis, in part contribute to immune dysfunction secondary to METH abuse This hypothesis will be tested by the following specific aims. Aim 1: To elucidate the pathophysiological effects of METH on T cell mitochondrial function. In order to understand T cell mitochondrial dysfunction caused by METH, first, we will assess the mitochondrial oxidative stress, mitochondrial permeability transition (MPT) and bioenergetics. Second, to gain insights to the molecular mechanism how METH affects mitochondrial function we will analyze mitochondrial proteome of HIV-1 infected or uninfected T cells following METH insult using two-dimensional difference in gel electrophoresis (2D-DIGE) combined with tandem mass spectrometry (MS/MS). Third, post-translational modifications of mitochondria enzymes will be identified with particular focus on complex I protein of electron transport system. Fourth, we will investigate whether impaired mitochondrial dynamics trigger cell death cascade and apoptosis. Activation of caspases -3 and 9, pro-apoptotic (Bax and Bak) and anti-apoptotic (Bcl-2 and c-myc) will be determined. These studies will be carried out in HIV-1 infected and uninfected T cells exposed to METH. Aim 2: To investigate the cellular signaling consequences of METH-induced mitochondrial dysfunction and correlate their role with T cell dysfunction. First, we will explore the idea that METH exerts its effects by activation of TAAR1 in a cAMP-depended fashion. Second, we will assess how the signaling events of TAAR-1 via cAMP and activation of PKA contribute to specific changes in METH-associated T cell dysfunction. Third, we will determine the mechanism through which METH-mediated oxidative stress alters MAPK-ERK signaling pathways. The potential consequences of METH-induced Ras and ERK activation and changes in phosphorylation of downstream targets (elF4e, p90RSK and S6K1) will be assessed. Fourth, we will study the impact of METH-induced mitochondrial oxidative damage and resultant altered gene expression on T cell cycle entry and progression. Aim 3: Analyze the affect of METH on immune dysfunctions using animal models of chronic viral infection (HIV-1 encephalitis model in SCID mice and lymphocytic choriomeningitis virus, LCMV mouse model). Using two different animal models, we will test the combined effects of METH and chronic viral infection: HIV-1 or LCMV on immune dysfunction. These "proof-of-concept" in vivo studies will evaluate how METH regulates T cell-cycle entry and progression, level of proliferation and apoptosis contribute to T cell dysfunction. First, cell cycle analysis, differentiation of CD8+ T and proliferation assays following non-specific and/or antigen stimulated T cells will be performed. Second, experiments will be performed in parallel to measure immune correlates; HIV-1/LCMV specific cytotoxic T-lymphocytes (CTL, CD8+, IFN-g+) and the cytotoxic potential of T cells (perforin expression, degranulation activity, and granzyme B expression) by flow cytometry. Third, as indicators of oxidative stress, levels of GSH and heme oxygenase-1 (HO-1) in the tissue and serum samples will be estimated in parallel. The proposed research is innovative because to date, no studies have evaluated the principal cellular mechanisms that contribute to T cell immune dysfunction secondary to METH abuse Collectively, we expect these experiments will greatly add to our understanding of underlying mechanisms leading to METH-induced immune deregulation and help develop interventions that could facilitate manipulation of T cell immune response to ameliorate or promote the recovery of immune response and better efficacy of HIV-1 treatment.